Mechanisms of ciliopathy associated structural birth defects

PROJECT SUMMARY/ABSTRACT
Cilia are complex structures with more than 1,300 proteins involved in their formation and function. During
development, disruption of cilia function causes gestational lethality and mild to severe birth defects. Variants in
cilia proteins are causally associated with more than 35 ciliopathy syndromes. Ciliopathy patients have a wide
range of phenotypes affecting nearly every organ system. Despite the cilium's clinical importance, the functions
of the cilium and molecular pathways the cilium regulates are poorly defined. To understand the
pathophysiological mechanisms driving ciliopathy birth defects, we are extending and utilizing protocols,
expertise, and tools developed within the UAB U54 Center for Precision Animal Modeling (CPAM). We will
identify and characterize variants of interest derived from patient and variant repositories from local, regional,
and national/international sources. Both variants of unknown significance (VUS) in known ciliopathy genes and
predicted deleterious variants of interest identified in novel candidate ciliopathy genes that we prioritize through
this application will be selected. Each variant will undergo robust assessment based on known or predicted
deleteriousness, pathway and protein interactions, and phenotype and functional associations as compared to
known ciliopathies. Prioritized variants will be subjected to a robust wet lab process to test pathogenicity,
determine ciliopathy protein cellular localization, and screen rapidly for cilia related phenotypes in zebrafish F0
Crispant mutants. For variants that remain highly prioritized after these steps, we will generate precision
engineered mouse models corresponding to the patient variant. These models will undergo phenotype analyses
to assess the clinical correlation between the model and the patient. We will analyze the variant's impact on cilia
assembly, morphology, formation of specialized cilia sub-compartments, and disruption of cilia protein interaction
networks. We will determine the impact of the variant on developmental signaling pathways known to be
associated with the cilium as well as identify novel pathways not previously identified as being regulated by the
cilium. To accomplish the goals of project, we have assembled a team with a wide range of expertise in medicine,
genetics and molecular diagnostics, computational biology, bioinformatics, and data science, biochemistry, cell
biology, and animal model generation and phenotyping. Collectively we will confirm the functional impact of
variants identified in patients with ciliopathy-like birth defects and patients with variants in genes predicted but
not already well known to affect the cilium or its activity. The outcomes from this project will uncover novel cilia
protein interactions and subcomplexes involved in cilia formation and maintenance, cilia protein transport, and
cilia sensory and signaling activities. This work will also support definitive diagnoses for patients with cilia
associated birth defects and generate data that can be used to predict potential therapeutic strategies. We will
also develop and disseminate patient relevant models and bioinformatics tools for the broader community.

Public health relevance
PROJECT NARRATIVE Ciliopathies are complex genetic disorders that can exhibit severe birth defects due to abnormalities in the formation or function of the cilium. A large number of proteins are thought to be involved in the cilium, but in only a few of these do we know the molecular pathways in which they function and whether they are associated with disease (ciliopathies). In this proposal, we take advantage of the explosion of genomic information from patients with rare developmental disorders and recent advances in identifying genes associated with the cilium to identify novel ciliopathies in rare and undiagnosed disease repositories, generate precision engineered mouse models corresponding to these patients, define the molecular and cellular pathways responsible for their birth defects, and generate data that can be used to predict therapeutic strategies through CPAM's drug discovery pipeline.